DNA damage responses to genome editing in hematopoietic stem cells

Project Summary
Several genome editing strategies have been developed for the treatment of genetic diseases that affect the
hematopoietic system, such as sickle cell disease and beta-thalassemia. Although there has been extensive
research on detecting off-target effects of genome editors, there is limited information on the genotoxicities of
on-target effects. The understanding of how hematopoietic stem and progenitor cells (HSPCs) resolve errors of
mitosis following DNA damage to prevent persistent chromosomal abnormalities is incomplete. For safer clinical
genome editing applications, understanding the frequency of such events is vital. We have shown in HSPCs that
Cas9-induced double-stranded DNA breaks (DSBs) resulting from genome editing of therapeutic loci can cause
chromosome segregation errors during cell division, leading to micronucleus formation and copy number
abnormalities of the telomeric chromosomal segment. Micronuclei (MN) can contribute to chromothripsis, a
genomic rearrangement phenomenon observed in cancer and other diseases. This proposal explores the
potential for persistent aneuploidies, including chromothripsis, in HSPCs resulting from genome editing and the
mechanisms of DNA repair in response to genotoxicities. Preliminary data generated from K01-supported
research demonstrates that genome editing of HSPCs at specific targets allows for the enrichment of edited cells
using pharmacologic and flow cytometric methods. Aim 1 will extend this observation both in vitro and in vivo by
performing genome editing of therapeutically relevant genes centromeric of the selectable gene. Isolated cells
will be subject to whole genome sequencing to reveal the nature of chromosomal rearrangements. This analysis
will reveal the capacity of aneuploid HSPCs to survive and the heritability of rearrangements during the process
of hematopoiesis. Secondly, our preliminary data show the inhibition of p53-mediated responses to DNA damage
or caspase inhibition reduces the frequency of MN. Aim 2 will study how p53 and caspases may contribute to
genome instability as a means of preventing persistent errors of DNA repair, allowing for the elimination of
HSPCs with somatic mutations. Together, the proposed studies will provide a deeper understanding of on-target
adverse events related to genome editing to better inform future genetic therapies. Data generated through this
R03 award will provide preliminary data for future R01 applications on mechanisms of DNA repair in human
HSPCs while supporting my transition from K01 recipient to independent investigator.

Public health relevance
Project Narrative Unrepaired DNA double-strand breaks induced by Cas9 genome editing lead to the creation of micronuclei and potential enduring alterations in chromosomes. This proposal aims to deeply investigate and address these harmful effects, focusing on understanding why errors persist post-editing and delving into the specific pathways that safeguard the genetic integrity of human hematopoietic stem and progenitor cells. This research aims to refine the safety and efficiency of clinical genome editing while advancing our understanding of preserving the genetic stability in stem cells.